Research Training in Natural Product Complementary and Integrative Health - Diversity Supplement to T32 Predoctoral Training Grant

PROJECT SUMMARY/ABSTRACT
Training young scientists for careers in natural products and dietary supplements research is a core mission of
the Pharmaceutical Sciences Ph.D. program at the Oregon State University College of Pharmacy and is the
focus of this predoctoral training grant. To address the need to train a new generation of experts in research
concerning natural products drug discovery and in the safety and efficacy of dietary supplements, this T32
training grant enrolls 5 predoctoral trainees at a time. Our mentor team includes faculty with expertise in
marine, microbial and botanical natural products and dietary supplements as well as natural product genomics,
cancer therapy, chemoprevention, pharmacology, dietary supplements, and biosynthesis. Our leadership team
includes co-Program Leaders with experience leading a T32 training program (Dr. van Breemen) and
experience serving as a director of graduate studies for our department (Dr. Mahmud). In response to the need
to enrich the diversity of pipeline of natural products scientists, we recruited two Hispanic/Latina graduate
students who joined our Ph.D. program during the Fall Term 2022. One of these students filled a T32 slot that
opened upon the graduation of one of our trainees. We are requesting a 12-month diversity supplement to
temporarily support the other graduate student from an under-represented group in the biomedical sciences.
This supplement will support her until another T32 slot becomes available. Currently, this other Hispanic/Latino
student is being supported by the OSU College of Pharmacy.

Public health relevance
Project Narrative The requested supplement for a 12-month training slot will enable this T32 to support and retain a predoctoral trainee from an under-represented group who will be carrying out research on the discovery of new therapeutic agents from natural product sources.